Uncovering the genetic mechanisms of the Chromosome 17q21.31 Tau haplotype on neurodegeneration risk in FTD and PSP

PROJECT SUMMARY (PROJECT 2)
Common and rare variants at the 17q21.31/MAPT locus contribute to Frontotemporal Dementia (FTD-tau) and
the Frontotemporal Lobar Degeneration (FTLD) spectrum disorder, Progressive Supranuclear Palsy (PSP).
Dominantly acting, rare missense and splice-site mutations in the MAPT gene have been reported to cause both
FTD-tau and PSP. Interestingly, it appears as though the majority of reported pathogenic MAPT mutations
causing familial PSP and FTD-tau occur on the H1 haplotype background, which is consistent with the increased
genetic risk associated with this haplotype in sporadic disease, although P301L, N279K and IVS10+16 have
been described on both haplotypes. However, it is unknown whether these haplotypes inﬂuence the phenotypic
expression of MAPT mutations. In addition to rare variation contributions to disease in this region, the strongest
genome-wide association signal for common variation in PSP is in the 17q21.31/MAPT locus. Identiﬁcation of
causal variants in this region has been hampered by the broad patterns of linkage disequilibrium created by the
970 Kb chromosomal inversion, which limits local recombination. Work by our group and by others, including our
preliminary data using massively parallel reporter assays (MPRA), indicates that this 17q21.31/MAPT region
harbors several different risk loci and hundreds of contributory common causal variants. Furthermore, because
>96% of patients with PSP have the H1 haplotype, the effects of these SNPs driving this major association signal
likely occur in the context of the H1 haplotype, and not H2. These observations lead to two major hypotheses
that drive this project: 1) H1/H2 haplotypes not only inﬂuence risk for sporadic FTD-tau/PSP but also modulate
expression of the pathogenic phenotypes associated with speciﬁc MAPT variants. Therefore, we hypothesize
that the changes to chromatin structure and gene expression or splicing that occur in H2/H2 neural cells
compared to H1/H1 will ameliorate the pathogenic effects of PSP/FTD MAPT mutations; and 2) That the
regulatory effects of common PSP-associated variation in this region will be similarly blunted on an H2 haplotype.
We will use a combination of single-cell genomic, and proteomic approaches to characterize the impact of
PSP/FTD-associated MAPT mutations in human brain tissue and in iPSC-derived assembloids. We will use
CRISPR genome editing to introduce PSP/FTD-associated MAPT mutations into cell lines from Project 1 with
either H1/H1 or H2/H2 backgrounds, and will use single-cell multi-OMICs (RNAseq and ATACseq) combined
with proteomics and ISOseq to comprehensively assess the impact of the mutations on each background. We
will further characterize the impact of MAPT mutations on disease-associated phenotypes on each background
using cellular and molecular assays, and will then use CRISPRa/i screens to validate the functional
consequences of key haplotype-associated regulatory regions containing candidate common causal variants on
disease-related Tau phenotypes on gene expression in both H1 and H2 haplotypes, in order to test the
hypothesis that causal disease variants have more activity on the H1 background.

Public health relevance
PROJECT NARRATIVE (OVERALL) The overall goal of the CWOW is to use multi-omics and functional genomics CRISPR screens to understand the molecular and cellular differences in gene expression and cellular function as a consequence of the H1/H2 haplotype inversion, and the resulting effects on risk for sporadic and familial tauopathies, leading to novel therapeutic targets for treatment of tauopathies.